Diverse and dynamically regulated mRNP composition regulating translation

ABSTRACT
Cells tightly regulate translation initiation in order to control which proteins they synthesize and
how much of each protein they produce. This regulation of protein synthesis matches translation
levels with the cell's translational capacity and physiological needs. Translation initiation, in
particular, is a key point for both global and transcript-speciﬁc regulation. In the canonical
pathway for translation initiation, an mRNA is ﬁrst activated by the formation of a closed-loop
complex bridging between the 5'-methylguanosine cap and the 3'-polyadenylate tail. A small
ribosomal subunit, accompanied by a variety of other initiation factors, is recruited to the mRNA
and scans in order to begin translation at the ﬁrst AUG.
Recent evidence suggests that translation initiation does not proceed down such a uniform
pathway. Individual translation factors are subject to regulation downstream of major signaling
pathways, including MAP kinase cascades, mTOR kinase signaling, and the integrated stress
response. Activation or inhibition of core translation initiation factors can produce transcript-
speciﬁc changes in translation, leading to broad translational reprogramming. Translation of
developmentally regulated genes also depends on cryptic initiation factors such as eIF2A,
eIF2D, and DENR/MCTS-1.
Our motivating hypothesis is that this heterogeneous landscape of translation initiation
complexes underlies dynamic, mRNA-speciﬁc control of protein synthesis. Here, we propose to
use proximity labeling of protein and RNA in order to survey the composition of translation
initiation complexes that assemble in vivo and understanding how this changes in response to
physiological and environmental signals. We will couple this with an analysis of translational
across the transcriptome. Together, these results will reveal the full diversity of pathways for
translation initiation in vivo and show how these different pathways mediate translational
expression programs.

Public health relevance
NARRATIVE Cells control which proteins they synthesize in response to internal and external signals. We propose to learn the different ways that cells can initiate translation, and how these different pathways allow cells to regulate protein production. By learning how cells control protein synthesis, we will better understand how cells control growth and respond to stresses.